California National Primate Research Center (CNPRC) - NIA Supplement

OVERVIEW ABSTRACT The California National Primate Research Center (CNPRC), located at the University of California, Davis, requests supplemental funds to the base operating grant #P51-OD011107. Currently in the 58th year of operation, the CNPRC serves a range of NIH-supported investigators and industry partners nationwide. From inception through the current year, the CNPRC has been highly responsive to the research community by providing high quality animals, facilities, tools, and services driven by the intellectual infrastructure of the Core Scientists in the service of our Mission: “To improve human health and quality of life through support of exceptional nonhuman primate research programs”. The supplemental funds requested fit within the following Specific Aims: (1) Conduct state-of-the-art research and scientifically contribute to the understanding and treatment of human disease with nonhuman primate models across the age spectrum, (2) Provide exceptional nonhuman primate expertise and services to investigators at the local, regional, and national levels to advance NIH-supported research excellence, (3) Mentor and train the next generation of translational investigators with nonhuman primate expertise, (4) Ensure the highest standards of responsible conduct of research and animal care, and 5) Stabilize and expand the NIA-funded colony of aged rhesus monkeys. We will continue to emphasize team science aimed at major human health problems across the lifespan, with the goal of moving beyond traditional interdisciplinary efforts to true convergence on the research problems being addressed. In this P51 Revision, support is requested to expand our National Institute on Aging (NIA) funded colony of aged rhesus monkeys. This program is integral to our ongoing research efforts focused on health across the lifespan. We are committed to providing a wide range of research opportunities that maximize use of the nonhuman primate model to improve human health with respect to age-associated diseases and declining function.

Public health relevance
OVERVIEW PROJECT NARRATIVE The CNPRC is an established national resource that has as a primary mission to improve human health and quality of life through support of exceptional nonhuman primate research programs that advance our knowledge of the causes, preventions, treatments, and cures of debilitating diseases. This mission is pursued through robust and well-developed on-site research programs, facilities, and expertise that are significantly augmented by collaborative programs that serve the greater biomedical research community. We are particularly committed to understanding health and diseases across the entire lifespan, and our geriatric colony of rhesus monkeys is a critically important contributor to this effort.